Other Function: Contract to purchase research services for Contract N01DA-08-5540

The purpose of this contract is to establish the Coordinating Center for CJ DATS2. The Coordinating Center shall provide support and coordination functions for the CJ-DATS 2 research cooperative and its Steering Committee, as well as support for the Data Safety Monitoring Board (DSMB) of the Division of Epidemiology, Services, and Prevention Research (DESPR), which will oversee CJ-DATS 2 clinical trials.